Racial Disparities and Colorectal DNA Methylation- Driven Gene Expression

ABSTRACT
Racial disparities in colorectal cancer (CRC) are widening. There are well-documented racial
differences in anatomical location distribution of CRC. African Americans (AAs) are more likely to develop right
side CRC and diagnosed at younger age than European Americans (EAs). The mechanisms underlying these
observed racial disparities and the relationship to sidedness remain poorly understood. DNA methylation is a
key epigenetic regulator of transcription. Epigenetic alterations result in accelerated aging and changes in gene
expression, which are believed to drive colon tumorigenesis. In a recent study of colorectal biopsies from 128
patients, we discovered that human colon exhibits remarkable racial and side differences in DNA methylation
and epigenetic aging. The right colon of AAs shows enrichment of hypermethylated differentially-methylated
positions (DMPs) and accelerated epigenetic aging whereas the right colon of EAs shows decelerated aging as
compared to left colon. Our analysis of rectal DNA methylation shows similar racial differences. We further
show that in patient-derived normal colon organoids, response to environmental exposures is colon side
specific and impacts global gene expression, further implying differing biology between right vs left colon, and
vs rectum. These novel observations led to our central hypothesis that there are distinct epigenetic and
transcriptomic perturbations underlying racial disparities in the development of site-specific colorectal
neoplasia. We here propose to perform RNA-sequencing of 384 individual-matched triplet colorectal biopsies
(right vs. left colon vs. rectum) from the 128 patients in our hands. In combination with DNA methylation data
already generated on these patients, we will use a supervised approach to integrate omics data on the
transcriptome and methylome, and to identify DNA methylation-driven gene expression signatures that may
provide biological insight of the racial disparities and colorectal site differences observed. In Aim 1, we will
identify within-individual site-specific DNA methylation-associated gene expression signatures across
colorectum locations (right vs left colon vs rectum). In Aim 2, we will identify cross-individual racial differences
in site-specific DNA methylation-associated gene expression signatures. In Aim 3, we will identify gene
expression signatures associated with site- and race-specific epigenetic age acceleration. Our study will
provide novel insight of the epigenetic and transcriptomic underpinnings of racial disparities in risk of site
specific CRC, and guide the development of prevention strategies to reduce racial disparities by targeting
critical epigenetic/transcriptomic pathways linked to colon carcinogenesis.

Public health relevance
Project Narrative This project aims to identify racial differences in DNA methylation-driven gene expression profiles between the right vs. left colon, and vs. the rectum.